Project 3: Regulatory RNAs as Cancer Drivers and Dependencies

PROJECT 3 – REGULATORY RNAS AS CANCER DRIVERS AND DEPENDENCIES
PROJECT SUMMARY
Long non-coding RNAs (lncRNAs) represent a large and relatively understudied class of RNA molecules that
have great potential to provide novel opportunities to influence gene regulation and cancer biology. The long-
term goal of Project 3 is to identify lncRNAs that are over-expressed in basal-like triple negative breast cancer
(B/TNBC) and basal-like pancreatic ductal adenocarcinoma (B/PDAC), define their roles in the disease, and
develop approaches to manipulate their expression in vivo to impact cancer progression and metastasis.
MALAT1 lncRNA has been shown to be upregulated in over 20 different cancer types and high expression of
MALAT1 has been shown to be associated with the propensity to metastasize, poor patient outcome, and drug
resistance. In Aim 1, a series of studies are proposed to determine the role of human MALAT1 lncRNA, taking
advantage of a recently established innovative patient-derived breast tumor organoid BioBank containing
organoids from various tumor sub-types as well as normal breast organoids. RNA antisense purification of
MALAT1 followed by mass spectrometry (RAP-MS) will be carried out to identify common and tumor-specific
MALAT1-associated proteins with a specific focus on proteins involved in transcription and/or pre-mRNA splicing.
To probe the role of MALAT1 in cancer progression, ASO-mediated knockdown (KD) will be carried out to assess
alterations in gene expression and pre-mRNA splicing, as well as impact on tumor growth and metastasis in
patient-derived organoid xenograft (PDO-X) models +/- standard-of-care drugs. In Aims 2 and 3, a series of
studies are proposed to determine the function of several recently identified lncRNAs that are significantly
upregulated in both B/TNBC and B/PDAC. Cellular fractionation and a CRISPR screen will identify those
lncRNAs that are chromatin-associated and essential. Chromatin Isolation by RNA Purification (ChIRP) coupled
to deep sequencing and RAP-MS will be used to identify genes that these lncRNAs regulate, and critical
protein interactors. Candidate lncRNA function in proliferation, migration, invasion will be assessed upon ASO
KD and over-expression studies. The impact of lncRNA loss on gene expression, pre-mRNA splicing, and
chromatin structure, as well as therapy response, will be evaluated. PDO-X models will be used to study tumor
growth and metastasis in vivo and to assess the impact of lncRNA KD on tumor progression. These studies will
define the functions of several newly identified chromatin-associated lncRNAs that are over-expressed in both
B/TNBC and B/PDAC, and determine their role(s) in gene expression as well as their potential as therapeutic
targets. Together, the proposed studies in this Project will address the function of a set of nucleic acid therapeutic
targets and nucleic acid antisense-based therapies to impact cancer progression and metastasis.

Public health relevance
PROJECT 3 – REGULATORY RNAS AS CANCER DRIVERS AND DEPENDENCIES PROJECT NARRATIVE Project 3 will characterize the function of several long non-coding RNAs that are over-expressed in basal-like triple negative breast cancer (TNBC) and basal-like pancreatic ductal adenocarcinoma (PDAC). The impact of antisense oligonucleotide knockdown on cancer progression and metastasis will be studied using patient-derived organoid xenograft models. Insights gained from this study will significantly impact considerations of new therapeutic approaches to treat basal-like TNBC and basal-like PDAC.